ICF INTERNATIONAL, INC.:1295338 [18-003759] - Research Support Services for The Genetic and Rare Diseases (GARD) Information Center. POP: July 30, 2018 - July 29, 2019. POC: Brian Lind and Anne Parise

The purpose of this contract is to provide support services to continue operation of the Genetic and Rare Diseases (GARD) Information Center and its inter-related initiatives including the provision of a variety of additional research-support services to the National Center for Advancing Translational Sciences (NCATS) and the Office of Rare Diseases Research (ORDR).